Rapid Anatomic and Quantitative MR Imaging of the Skull Base and Face

PROJECT SUMMARY/ABSTRACT
Skull base and face imaging accounts for nearly 20% of clinical neuroradiology examinations. But clinical MRI
of the skull base and face continues to rely primarily on conventional 2D T1-weighted and T2-weighted pulse
sequences and fat suppression techniques. These techniques generate suboptimal tissue contrasts with
suboptimal spatial resolution. The long acquisition times often lead to motion artifact. Contrast weightings and
rapid acquisitions tailored to the uniquely small structures of the skull base and face would expand the clinical
utility of MRI for diagnosing pathologies of these regions. Dr. Guenette’s goal for this four-year K08 mentored
career development award is to gain the skills needed to develop comprehensive skull base- and face-specific
MRI sequences and protocols that optimize clinically relevant contrast-to-noise and simultaneously acquire
relaxometry biomarkers that are co-registered to the anatomic images at the voxel level with markedly reduced
scan times compared with current standard-of-care skull base and face MR imaging. Dr. Guenette is a
neuroradiologist with skull base and face sub-specialization at Brigham and Women’s Hospital. His research
has included optimizing product pulse sequences for imaging skull base and face structures. The training
objectives and research activities of this proposal will provide Dr. Guenette with the mentorship, time, and
resources to learn and apply MRI physics, pulse sequence design, and image processing. The main research
expertise of Dr. Guenette’s mentor, Dr. Bruno Madore, an MRI physicist, lies in the development of novel
acquisition and image reconstruction strategies for MRI. The co-mentor, Dr. Ravi Uppaluri, is an
otolaryngology-head/neck surgeon physician-scientist with complementary clinical expertise. In Aim 1 Dr.
Guenette will: build a normative atlas of quantitative T2, T1, and relative proton density values of anatomic
structures in the skull base and face; use this atlas to generate and test theoretically optimal contrasts for
nerve imaging; establish normative T2, T1, and relative proton density values of head and neck squamous cell
carcinoma (HNSCC) tumors to generate and test optimal contrasts for visualizing and segmenting HNSCC
tumors; and test the biomarker potential of T2, T1, and relative proton density measures in HNSCC. In Aim 2
he will: develop a novel pulse sequence that incorporates scanner gradient strength as a parameter to further
decrease scan times and evaluate synthetic pulse sequences across 1.5T, 3T, and 7T field strengths. The
training and data will facilitate Dr. Guenette’s long-term goal to independently lead an NIH-funded laboratory
focused on developing and implementing more rapid qualitative MR anatomic imaging and quantitative MR
methods specifically tailored to the skull base, face, and neck structures and pathologies.

Public health relevance
PROJECT NARRATIVE Our goal is to devise clinically optimal MRI synthetic image contrasts for the skull base and face that can be tailored for field strength, gradient capabilities, spatial resolution, and desired imaging time. We propose to generate novel qualitative MRI contrasts that optimize clinically-relevant contrast-to-noise and simultaneously acquire relaxometry biomarkers that are co-registered to the anatomic images at the voxel level with markedly reduced scan times compared with current standard-of-care skull base and face MR imaging. We also propose to develop a novel pulse sequence that incorporates scanner gradient strength as a parameter to further decrease scan times and to evaluate these pulse sequences across 1.5T, 3T, and 7T field strengths.